LIMITED CATALOGING OF LANGUAGE MONOGRAPHS

In order to maintain cataloging production for currently received monographs and monographic serial analytics in foreign languages as well as in English, the National Library of Medicine has a requirement for cataloging expertise to produce original limited cataloging records for up to 3000 titles in FY88; 4280 titles in FY89; and 4280 titles in FY90. Experience in applying the Anglo- American Cataloguing Rules is required and it is highly desirable that the contractor have a knowledge of Library of Congress AACR2 Rule Interpretations, NLM classification schedule and NLM's MeSH subject thesaurus.